Advancing next-generation CAR-NK therapies targeting CD5 positive T cell malignancies to the clinic

Summary:
Patients with relapsed/refractory (R/R) T cell malignancies have poor outcomes and novel therapies are urgently
needed. While CAR-T cells have shown remarkable efficacy in patients with B-cell malignancies and multiple
myeloma, targeting T-cell malignancies presents unique challenges. One of the major issues is fratricide due to
the shared expression of target antigens on both malignant and normal T cells, leading to self-targeting.
Additionally, there is a risk of product contamination with malignant T cells during the manufacturing process,
and the prolonged life-span of CAR-T cells poses the risk of long-term T-cell aplasia. In contrast, CAR-
engineered natural killer (NK) cells offer several advantages. Unlike T-cells, NK cells do not express T cell target
antigens such as CD5, eliminating the risk of fratricide. CAR-NK cells also avoid the issue of product
contamination with malignant cells, as they can be derived from healthy donors rather than the patient’s own
cells. Their shorter life-span reduces the likelihood of prolonged T-cell aplasia. Moreover, CAR-NK cells retain
their innate cytotoxicity while also providing tumor specificity against the target antigen through engineering,
without the concerns of graft-versus-host disease in the allogeneic setting, cytokine release syndrome or
neurotoxicity. Building on our successful first-in-human trial of cord blood (CB) derived CAR19/IL-15 NK cells in
patients with relapsed/refractory B-cell malignancies (published in NEJM 2020; Nature Medicine 2024), we now
propose a clinical trial targeting CD5 in T cell malignancies. Our engineered CAR-NK cells express an scFv
against CD5, IL-15 to enhance persistence, and an inducible caspase-9 (iC9) safety switch (collectively termed
iC9/CAR5-28ζ/IL-15 NK cells). A key innovation in this proposal is our novel ex vivo expansion protocol for CAR-
NK cells, incorporating IL-12, IL-18, TGF-β and Rapamycin to enhance the metabolic fitness of the cells.
Preclinically, iC9/CAR5-28ζ/IL-15 NK cells generated using this novel expansion strategy demonstrated potent
activity against T-cell lymphoma models. The clinical protocol has received IRB and FDA (protocol #2021-0526,
IND 30087) and is currently enrolling patients. In parallel, we will conduct state-of-the-art correlative studies to
comprehensively characterize the infused CAR-NK cells, tracking their persistence, trafficking, and immune
modulation in patients. Additionally, we have developed a robust genome-wide CRISPR screening platform to
identify novel regulators of CAR-NK cell function and mechanisms of resistance in T cell malignancies. Insights
from these studies will inform the development of next-generation CAR-NK cells, optimized to overcome immune
evasion strategies and improve patient outcomes. In Aim 1 we will conduct a Phase I/II clinical trial to test the
safety and efficacy of iC9/CAR5-28ζ/IL-15 NK cells in patients with CD5+ T cell malignancies. In Aim 2 we will
apply comprehensive correlative studies. In Aim 3, we will perform genome-wide CRISPR screens in both our
iC9/CAR5-28ζ/IL-15 NK cells and T cell malignancy cell lines to uncover novel mechanisms of resistance and
inform the design of next-generation CAR-NK cell therapies.

Public health relevance
NARRATIVE In this proposal, we seek to improve treatment outcomes for patients with relapsed/refractory T cell malignancies by evaluating the safety and efficacy of cord blood derived iC9/CAR5-28ζ/IL-15 NK cells in a Phase I/II trial. Moreover, by leveraging our cutting-edge genome-wide CRISPR screening platform, we will aim to uncover novel mechanisms of response and resistance to guide the design of next-generation CAR-NK cells for patients with T cell malignancies.